Hypovitaminosis D promotes MED12-associated genomic instability in uterine fibroids

Abstract of Funded Parent Grant UFs (leiomyomas) are the most important benign neoplastic threat to women’s health worldwide, with annual health care costs estimated in the hundreds of billions of dollars. UF caused- morbidities negatively impact women of all ethnicities, but disproportionately affect African American (AA) women, who have a threefold higher incidence rate and relative risk of UFs than Caucasian (CC) women. While the basis for this risk disparity is not fully understood, recent studies implicate hypovitaminosis D as a major contributor. Thus, AA women have a tenfold increased risk of vitamin D deficiency compared to CC women, and as we first reported, UF risk is inversely correlated with 25-hydroxy vitamin D serum levels. Nonetheless, it is not clear whether and how the processes that drive UF formation and racial risk disparity are genetically or biochemically linked. Herein, we suggest a mechanistic basis to couple UF etiology and relative risk association through a functional interplay between vitamin D3 and an altered DNA damage response network in MED12-mutant UFs, and further offer proof of concept for therapeutic intervention in this genetic setting. Recently, we and others identified somatic mutations in the transcriptional Mediator subunit MED12 as the dominant drivers of UFs, accounting for ~70% of tumors. Notably, MED12-mutant UFs are characterized by significant chromosomal loss and rearrangement, suggesting genomic instability as a driving force in tumor progression. Herein, we clarify the molecular basis for mutant MED12-driven genomic instability, and further identify vitamin D3 receptor signaling as a likely suppressor of this process. We show that MED12-mutant UF stem cells (SCs) accumulate high levels of unrepaired DNA double-strand breaks (DSBs) through downregulation of key DNA damage response (DDR) and repair genes, including RAD50, RAD51 and BRCA1. Notably, we find the vitamin D3/receptor axis to be a variable modulator of MED12-regulated DDR gene expression. Thus, we show that reduced vitamin D3/receptor signaling suppresses, while elevated signaling activates, DDR genes downregulated in MED12-mutant UF SCs. Based on these findings, we hypothesize that hypovitaminosis D exacerbates DNA damage accumulation and genomic instability arising in MED12-mutant UFs, leading to enhanced tumor progression and burden. Accordingly, we propose that vitamin D3, through reparation of an impaired DDR, will provide therapeutic benefit in MED12-mutant tumors. To confirm and extend these hypotheses, we propose the following aims, which directly address and mechanistically connect three overarching issues in the field: the molecular pathogenesis of UFs, the racial disparity in UF risk, and the development of novel tolerable fertility-saving and cost-effective oral therapies for UFs.

Public health relevance
Differential Transcriptomic Signature of Uterine Fibroids from African vs African American Women Project Summary Uterine fibroids (UFs) are the most common gynecologic tumors in premenopausal women and the leading indication for hysterectomy. UFs are also a major health disparity issue with a 3-4 times greater risk of occurrence in women of African descent compared to women of other races. It is estimated that 70-80% of Black women will have fibroids at some point. Fibroids are highly endemic within Sub-Saharan Africa. Despite this fact, most of the uterine fibroid research has been conducted outside of Sub-Saharan Africa. Our understanding of the molecular pathogenesis of UFs is rather limited. This led to limited innovation in designing novel medical therapeutics and surgery remains the mainstay in the form of hysterectomy. This invasive major procedure precludes future fertility of women and is associated with several other short and long term morbidities and occasional mortality. This is particularly a major challenge in sub-Saharan Africa where surgical and perioperative infrastructure is flailing. NICHD identified development of non- invasive non-hormonal treatment of uterine fibroids as a major research priority. We have published extensively on the utility of two natural products, vitamin D and EGCG (Epigallocatechin gallate, a green tea extract) for treatment of uterine fibroids in cell models, in UF animal models and in African American women with symptomatic uterine fibroids. Vitamin D and EGCG have never been evaluated in models for African UF. In this proposal, we are aiming to: 1) examine the transcriptional profiling in myometrium and UFs derived from African versus African American women with a focus on aberrations in DNA repair pathways, and 2) compare the inhibitory effect of EGCG and vitamin D3 intervention alone versus in combination as potential natural treatment on UFs derived from African versus African American women using our established renal capsule mouse model. Relevance For women with symptomatic fibroids who want to preserve fertility, there are currently limited conservative treatment options that will treat their fibroids without compromising subsequent chances of achieving a healthy pregnancy. Current fibroid treatment in Africa includes hysterectomy, myomectomy, and uterine fibroid embolization (UFE). 2 This proposal will help elucidate the effect of impaired DNA damage response to genomic instability and determine if EGCG and vitamin D3 supplementation are potentially effective nonsurgical and fertility-friendly treatments for UFs, specifically in women of African descent. EGCG inhibits key pathways of tumor growth by modulating signaling pathways involved in cell proliferation, transformation, apoptosis and inflammation. Roshdy et al showed that EGCG significantly reduced uterine fibroid volume in a group of Egyptian women. 3 Moreover, it has been demonstrated in both in vitro and animal models that vitamin D3 reduces leiomyoma cell proliferation and tumor growth.4